Task B05: Refinement of a Pig-Tail Macaque model of Gonococcal Infection

This contract provides for the development and standardization of non-human primate models of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.